Technology & Data Core

Project Summary – Technology and Data Core
The overall objective of the Michigan Infectious Disease Genomics (MIDGE) Center is the identification of
pathogen determinants of epidemic success. To accomplish this goal, each project will generate large genomic
compendia, and analyze them in the context of rich phenotypic measurements. The Technology and Data Core
(TDC) will support individual projects and the overall mission of MIDGE by providing intellectual capacity,
technical skill, and infrastructure to enable genomic and phenotypic data generation, analysis and
dissemination of data, resources, and results to the research community. The TDC is led by investigators with
expertise and experience in the generation and analysis of massive genomic data sets, performing high-
throughput phenotypic assays, and the integration of genomic and phenotypic data through advanced
phylogenetic analysis and microbial genome-wide association studies (mGWAS). In addition, the TDC includes
two technical staff with extensive experience in managing large and complex data sets, creating automated
workflows for data quality control, analysis and sharing and writing custom software solutions for both data
management and bioinformatic applications. With this leadership and technical knowhow, the TDC will fulfill the
following four objectives: i) facilitate genomic data generation, quality control and rapid dissemination of
cleaned sequence data, ii) provide capacity for extraction of genetic variation from cleaned sequencing data,
iii) provide support for laboratory automation, high-throughput phenotyping and integration of phenotypic and
genotypic data through advanced phylogenetic analysis and mGWAS, and iv) ensure consistent and uniform
sharing of data, protocols and software emanating from MIDGE. In fulfilling these objectives, the TDC will not
only provide direct support for all four research projects, but also act as a hub for the sharing of technical
knowledge and analysis pipelines across projects. Lastly, investigators and staff in the TDC will lend their
technical expertise in helping train team members across projects, which will enrich the training environment
associated with MIDGE, improve productivity, and ensure uniform standards and practices.